Singlet Oxygen-cleavable Prodrugs for Treating Non-Muscle Invasive Bladder Cancers

Bladder cancer (estimated 83,730 new cases and 17,200 death in 2021) is unique in that most (70-80%) of
patients are diagnosed with early-stage, non-muscle invasive bladder cancer (NMIBC). NMIBC is first treated by
transurethral resection (TUR) and then adjuvant transurethral therapies, such as intravesical BCG and
chemotherapy, for patients with high risk for advanced stages. However, recurrence remains a significant
problem. There has been no breakthrough in NMIBC treatment since BCG was FDA-approved for bladder cancer
treatment in 1990. Last year, the FDA approved pembrolizumab for treating BCG-unresponsive, high-risk
NMIBCs, but it is very expensive and its complete response rate is not very satisfactory. These days, the
shortage of BCG has become a problem in clinical practice. Our long-term goal is to develop a clinically
translatable NMIBC-treatment strategy to effectively and selectively kill cancer cells without collateral damage to
normal bladder tissue. Our hypothesis is that a mitochondria-localizing and singlet oxygen (SO)-activatable
prodrug is effectively activated by HAL (hexyl-5-aminolevulinate)-PDT in the mitochondria of cancer cells, thus
greatly improving therapeutic efficacy of HAL-PDT with minimal collateral damage. Recently, we proved and
advanced this novel SO-activatable prodrug concept in both intramolecular and intermolecular activation
manners. The combination of green light and intravesical administration is expected to avoid collateral damage
to normal bladder wall unlike traditional PDT. The objectives of this proposed work are 1) to develop SO-
activatable prodrugs of clinically used anticancer drugs for NMIBC and 2) to prove enhanced efficacy of this
combination treatment in both in vitro and in vivo models. An orthotopic rat model of bladder cancer will be used
to better mimic physiology of human NMIBC. Three specific aim are proposed: Aim 1) Develop mitochondria-
targeting and SO-activatable prodrugs of clinically used drugs for NMIBC, Aim 2) Determine uptake and the
combination effect using 3D cell culture and healthy bladders (rat and rabbit), and Aim 3) Determine the
anticancer effects and local side effects of the combination treatment using the orthotopic rat bladder cancer
model. This project is highly innovative in both conceptual and technical aspects. It is a novel approach to
address an important clinical problem using a highly multidisciplinary and integrative strategy. If successful, the
proposed research will provide new effective treatment strategy and prodrugs for treating NMIBC with high
likelihood of rapid clinical translation, because HAL and anticancer drugs have historically been used for NMIBC.
Due to the advances in optical and transurethral surgical technology and the unique accessibility of bladder,
there is no major technical barrier for implementing such strategy to clinical practice. We have been consulting
with practicing urological clinicians to gear our strategy towards clinical translation. Our strategy can also be
applied to post-surgical treatment of micro-metastasis of many other cancers (brain, GI malignancies, cervical
and ovarian cancers), for which HAL has been used for fluorescence diagnosis.

Public health relevance
About 84,000 patients are expected to be diagnosed with bladder cancer this year and about 70-80% of the patients will have non-muscle invasive bladder cancer (NMIBC), which is considered the golden time for cure of bladder cancer. Although intravesical treatments have been used following transurethral surgery, recurrence and progression to the advanced stage still remain critical problems. This proposed integrative project will provide new effective treatment strategy and prodrugs for treating NMIBC with a great potential for rapid clinical translation.